Role of adolescent stress in postpartum mood and cognition

PROJECT SUMMARY/ABSTRACT
Mood disturbance and cognitive impairment during the postpartum period are common and serious problems in
women's mental health. Early life stress, such as psychosocial stress during adolescence, increases the risk for
postpartum emotional and cognitive problems in humans, including the development of postpartum mood
disorders. Nonetheless, the biological mechanisms linking adolescent stress to postpartum emotional and
cognitive abnormalities are not well understood. Our long-term goal is to examine how pre-partum life stress
affects hormonal systems, neural function, and behaviors in the developmental trajectory from adolescence to
the postpartum period and dissect the mechanisms from molecules to circuits and behavior. Human imaging
studies have linked functional changes in the projections from the anterior insula (AI) to dorsal anterior cingulate
cortex [dACC, homologous to the prelimbic cortex (PrL) in rodents] to postpartum behavioral changes. Elevated
levels of glucocorticoids by disturbance of negative feedback of the hypothalamic-pituitary-adrenal axis during
the postpartum period can alter neural function. To gain more biological insight into these points, we have built a
novel platform to study the biological mechanisms underlying the effects of adolescent stress on postpartum
emotional and cognitive behaviors in first-time mothers, based on the adolescent social isolation paradigm we
have already published. Hence, our current objective is to test the hypothesis that adolescent stress, in
conjunction with the stressful events of pregnancy/delivery, leads to deficits in postpartum behaviors related to
mood and social cognition via glucocorticoid-mediated functional alterations of AI-PrL glutamatergic projections.
To address this hypothesis, we will pursue the following specific aims: In Aim 1, we will examine the role of
AI-PrL projections in adolescent stress-induced PrL dysfunction and behavioral deficits in adult postpartum mice
using a combination of state-of-the-art techniques, including in vivo calcium imaging in conjunction with
projection-specific neuronal manipulation in freely moving mice. In Aim 2, we will determine the role of
glucocorticoid receptor (GR) in adolescent stress-induced PrL dysfunction and behavioral deficits in adult
postpartum mice. In Aim 3, we will combine retrograde tracing and cell type-specific manipulation using the
green fluorescent protein (GFP)-dependent Cre recombinase system to examine the causal role of
GR-mediated AI-PrL glutamatergic projections in the PrL dysfunction and behavioral deficits in adult postpartum
mice pre-exposed to adolescent isolation rearing. Our findings may provide biological insights into postpartum
mood disturbance and cognitive impairment, which are highly prevalent and have deleterious effects not only on
the mother, but also on the children and the rest of the family. These findings will have a broad impact on the
well-being of women and children worldwide.

Public health relevance
PROJECT NARRATIVE This New Investigator will study the biological mechanisms by which psychosocial stress during adolescence alters first-time mothers' behavioral patterns related to mood and social cognition in the postpartum period. Studying longitudinal effects of adolescent psychosocial stress on adult postpartum behaviors will be innovative approach to understand how pre-partum life stress affects hormonal systems, neuronal function, and behaviors in the developmental trajectory from adolescence to the postpartum period.